EFFECTS OF AN AQUEOUS EXTRACT OF BEANS ON PLASMA LIPOPROTEINS

The aim of this study is to determine whether an aqueous extract from boiled beans lowers plasma total and LDL cholesterol in men with moderate hyper-cholesterolemia using a double-blind, placebo-controlled, crossover study design.